Community Engagement Core

Abstract – Community Engagement Core
Heath Disparities (HD) disproportionately affects racially and ethnically diverse communities and are the result
of a complex set of factors that have historical, social, political, and environmental roots. Addressing HD requires
meaningful partnerships across stakeholders that operate from community-based and community engagement
principles. North Carolina Central University’s (NCCU) RCMI Center for Health Disparities Research (RCHDR)
includes a Community Engagement Core (CEC) with a goal of strengthening community engagement and
building strong partnerships with community stakeholders in underserved, minority communities of North
Carolina. During initial funding we were able to establish the CEC as a community-centered and trusted source
with several key focus areas. In addition to our community facing efforts and activities, part of the community
capacity building focused on researchers where we convened a group committed to thoughtful and ethical
research, as seen in our ‘Research with Care’ brand, of ‘TEAM NCCU’. In this competitive renewal, through
innovative and culturally appropriate community engagement efforts, the NCCU-CEC will continue to build and
support community capacity, establish relationships with community-based organizations, and public health
departments, be responsive to health needs, promote culturally competent research, increase research
participation, and disseminate findings from RCHDR research projects. Objectives of the CEC include 1)
Fostering sustainable community partnerships by creating a community-based network (CBN), 2) Leveraging
expertise to support and build capacity for and in our underserved communities, and 3) Establishing a bi-
directional Community Research and Translation Hub to disseminate health information and research findings
to diverse community stakeholders.

Public health relevance
Narrative Racial and ethnic health disparities in the US have been made worse by COVID19, thus, increasing its awareness and its need to be addressed. The role of HBCUs in addressing and being represented in the community has proven to be essential to the resolution of these disparities. Through this competitive renewal, NCCU’s RCMI Center for Health Disparities Research (RCHDR) will continue enhancing NCCU’s research ecosystem to develop successful scientists conducting impactful and cutting-edge research to address health disparities (HD) and achieve health equity.